Implementation Solutions, and Evaluation Core

ISE Abstract
Evaluation and dissemination of evidence-based solutions to mitigate the health effects of heat stress can curb
the anticipated increases in heat-related morbidity and mortality in the coming decades due to climate change.
However, little research to date has considered how to evaluate and disseminate locally-appropriate climate
and health solutions across diverse global contexts. Doing so requires careful attention to the local context and
resources, how the interventions are delivered and received by the community, and the types of quantitative
data and dissemination products most valuable to decision-makers. Adopting an implementation science (IS)
perspective, which has scarcely been applied in the climate solutions setting, can assist us in designing and
evaluating climate change solutions in a manner that increases the likelihood they will be spread and utilized.
The Implementation, Solutions and Evaluation Core (ISE) of C-EARTH will conduct rigorous evaluations of the
impacts of the cooling solutions under study at each project site (Boston, Madagascar, and South Africa) and
will advance the translation of these solutions into policy through the design of responsive dissemination
products developed using an innovative approach to participatory IS for climate change and health.
Specifically, the ISE aims to provide the following services and supports at each project site: (1) conduct robust
quantitative and qualitative data analyses to assess the effectiveness and implementation of cooling solutions
and community engagement; (2) use participatory approaches to support policy translation of solutions
(including economic evaluations and co-design of dissemination products) at local, regional, and national
levels; and (3) co-develop and offer capacity-building interventions for researchers and local leaders to support
a “designing for dissemination” approach to solution generation. To ensure success of these aims, we have
assembled a team with rich expertise in implementation science, community-engaged research, biostatistics,
environmental health, and economic evaluation, and we will leverage long-standing partnerships that C-
EARTH’s leaders have with community leaders and policy-makers in the three settings. The work of the ISE
will also be closely integrated and synergistic with the projects, the CEC, and the NIH Climate Change and
Health Research Coordinating Center. In addition to providing essential supports to enhance the rigor and
impact of the work undertaken by C-EARTH, the ISE will serve as a pioneering model of applying participatory
IS approaches to advance climate change and health solutions. Broader application of such approaches will
increase uptake of climate change-focused evidence-based solutions and facilitate transformational policy
change to reduce the health risks of climate change.